Administration

Administration The Administration provides central programmatic leadership and coordination to improve and foster collaboration, to manage future planning, and to facilitate communication between investigators, programs and projects, cores, and other Center participants. The Administration develops and implements the policies and procedures of the Center and guides daily operations. It manages the allocation and distribution of Cancer Center resources for cancer research. The Cancer Center Administration is responsible for general administrative services; human resources; financial management including sponsored programs; information technology & systems development; strategic, program and technology planning; research resources management; coordination with clinic and clinical research; facilitation of community and member relations. The Administration Unit has a complement of 30 staff members with a total 2007 budget of $1,956,717 of which $447,653 or 23% is requested as the CCSG component.